A robotic enteroscope for safe and effective access to the small bowel

Abstract
Drive Medical is developing the Pollywog , a robotic enteroscope that enables gastroenterologists of all skill
levels to access the small intestine easily and quickly. Problems with the small intestine can include bleeding,
Celiac disease, Crohn’s disease, infections, inflammation, polyps, and cancer. Patients suspected of having a
small intestine disorder must be referred to a highly skilled gastroenterologist who can perform a deep
enteroscopy to visualize the small bowel. Deep enteroscopy is a highly complex procedure, given the shear
length that an endoscope must be advanced into the intestine, anatomical complexity of the small intestine, and
the anatomical variation between patients. Unfortunately, deep enteroscopy is the only procedure that allows for
a comprehensive small intestine examination – less labor-intensive alternative options, including capsule
endoscopy, make precise location of intestinal areas of interest difficult, and unable to provide tissue sampling
and interventions, thus limiting the usefulness of any findings. As such, Drive Medical is developing a device that
enables gastroenterologists of any skill level to perform examinations and procedures in the small bowel. The
Pollywog is a disposable soft robotic endoscope that uses a self-driven double balloon mechanism that inches
through the full length of the small and large intestines. Since the Pollywog uses technology that allows it to crawl
through the intestine, the movement mechanism of action resembles pulling, rather than pushing (like traditional
deep enteroscopy methods). The Pollywog’s self-driven crawling mechanism enables fast intubation speed while
avoiding trauma to the luminal wall, thus reducing the need for sedation and making perforations less likely when
enteroscopy is being performed by gastroenterologists of all skill levels. With its deep intubation capability and
intervention channel, the Pollywog is a key enabling technology for multiple indications that are related to small
intestine disorders. In Phase I, Drive Medical seeks to demonstrate that the Pollywog achieves access to the
small intestine without increased patient risk, and show that less skilled gastroenterologists can quickly achieve
access and navigate the small intestine. This will confirm the feasibility of the Pollywog to enable more
gastroenterologists to adequately perform deep enteroscopy without increasing risk. The specific aims of this
Phase I project are: 1) Develop a functional Pollywog navigation system and confirm risk-minimal functionality
and 2) Perform a usability study with GIs to confirm that the Pollywog lowers the barrier to accessing the small
bowel compared to double balloon enteroscopy. This work will set up a Phase II in which Drive Medical can use
the gastroenterologists’ feedback to make design changes and then begin safety and efficacy testing to use for
a regulatory submission. Further proposals would explore the performance of the Pollywog under multiple
disease states, thus validating the ability of the Pollywog to increase access to care for patients with a variety of
small intestine disorders.

Public health relevance
Narrative Access to examinations and interventions in the small bowel, requiring highly skilled gastroenterologists, is limited across all regions of the country, thereby restricting the number of individuals who can undergo these procedures and receive proper healthcare. Drive Medical is making a device that makes accessing the small bowel easier and faster without posing additional risks to the patient when the enteroscopy is performed by a less-skilled provider. With its deep intubation capability and intervention channel, the Pollywog is a key enabling technology for multiple indications that are related to small intestine disorders, making access care more accessible and opening new pathways for research and development.